IPP NCI FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC) CONTRACT TO-F

The purpose of this project is to replace the existing Class B fire alarm system
with a modern, addressable Class A fire alarm system.